Myocardin-related transcription factor (MRTF) pathway modulators as a novel, disease-modifying oral medicine for idiopathic pulmonary fibrosis (IPF)

Abstract
The overall objective of this project is for OncoArendi Therapeutics (OAT) to develop a myocardin-related
transcription factor (MRTF) pathway inhibitor as a novel, disease-modifying oral medicine for
idiopathic pulmonary fibrosis (IPF), with superior medical benefit and improved safety and tolerability
compared to current treatments. The main goal of this Phase I proposal is the selection of a compound to
enter IND-enabling studies.
IPF is a chronic, progressive and fatal fibrotic lung disease, with a median survival of 3-5 years after
diagnosis. Current treatment options for IPF are limited with minimal efficacy and significant tolerability issues.
It is estimated that about 5 million people worldwide suffer from IPF. Thus, IPF represents a serious, common
disease with a massive unmet medical need for new medicines that will improve morbidity and mortality.
Literature reports have provided evidence that the MRTF pathway is critical to the initiation and progression
of fibrosis, and underpins the various processes that are responsible for fibrosis. One of the current standard-
of-care treatments for IPF, pirfenidone, inhibits MRFT activation, albeit in very high concentrations. Thus,
selective and potent MRTF pathway inhibitors offer an innovative strategy to attenuate fibrosis. OAT has
identified MRTF pathway inhibitors, with the most potent compound, OAT-5116, having an IC50 of 50 nM in the
primary screening assay, involving inhibition of MRTF/SRF dependent luciferase assay on transfected HEK293
T cells. OAT-5116 is >1000-fold more potent than pirfenidone (IC50 >100 µM) in this assay. The two key Aims
of this proposal are: Specific Aim 1: Lead Optimization to identify a Clinical Development Candidate
(CDC). A detailed Medicinal Chemistry strategy has been developed to synthesize and test novel analogs of
the current chemical pharmacophore, and address the developability liabilities of the lead compound, OAT-
5116, including poor oral pharmacokinetic profile in rodents, high plasma protein binding, and hERG potassium
channel inhibition. All the relevant in vitro and in vivo biological and DMPK assays have been established.
The ultimate goal of these studies is the selection of a CDC compound with the appropriate biological,
chemical, DMPK and developability characteristics to progress into IND-enabling studies. Specific Aim 2:
Effects of the CDC in the Bleomycin-induced Model of IPF in Mouse. The dose-response effects of oral
administration of the CDC compound will be examined in the bleomycin-induced pulmonary fibrosis model in
mouse, the gold-standard rodent model of IPF. The compound will be administered using a therapeutic
treatment paradigm and its effects will be compared with those of oral pirfenidone, a current treatment for IPF.
The results from this Phase I application will expand the scientific rationale for an MRTF pathway
inhibitor as an innovative, disease-modifying oral therapy for IPF, and lay the foundation for the future clinical
development of the optimized compound that OAT selects for progression to IND-enabling studies.

Public health relevance
Narrative Idiopathic pulmonary fibrosis (IPF) is a chronic, progressive and fatal disease of the lung, which is estimated to affect 5 million people worldwide, and which only has an average survival of 3-5 years after diagnosis We are conducting research, including the use of disease-relevant animal models, on a new type of potential oral medicine, a MRFT pathway modulator, for IPF that has the potential to provide superior medical benefit and improved safety compared to current treatments, and will increase survival and the quality of life for IPF patients. The results from the studies outlined in this application will be an important step towards the clinical testing of an oral MRFT pathway modulator compound in patients with the deadly disease of IPF.